Reducing racial disparities in lung cancer outcomes by decoding neighborhood contextual environment (RECODE)

ABSTRACT
This application proposes to examine a novel social epigenetic mechanism for racial inequality in lung cancer:
Reducing racial disparities in lung cancer outcomes by decoding neighborhood contextual environment
(RECODE). We will examine the relationships between exposure to violence, inflammatory responses,
smoking and epigenetic changes in protein arginine methyl transferases (PRMT6) that increase the risk of
developing lung cancer. Our preliminary studies demonstrated that smoking induces increased expression of
PRMT6 in the lung epithelium. We also showed that overexpression of PRMT6 triggers spontaneous lung
tumors in mice. Interestingly, we found that PRMT6 is upregulated among black men compared with white
men in The Cancer Genome Atlas (TCGA). Thus we argue that the increased overexpression of PRMT6
among black men may explain a higher rate of lung cancer among black men compared with white men. While
smoking is a key contributing factor for lung cancer, the frequency and amount of cigarette smoking are not
necessarily higher for blacks, which suggests that other factors are responsible for racial disparity in lung
cancer. Disproportionate social stress in black communities may be responsible for a higher rate of lung
cancer among blacks. In particular, individuals living in excessive neighborhood violence are exposed to
chronic stress, which may intensify the epigenetic changes for lung cancer. We hypothesize that exposure to
neighborhood violence is social stress that increases biophysical inflammatory responses, which exacerbate
the path between smoking, PRMT6 overexpression, and lung cancer.
To examine the proposed social epigenetic mechanism of lung cancer disparity, first, we will test the
independent effect of smoking and exposure to neighborhood violence, and the interaction of the two risks on
PRMT6 expression using retrospective tissue samples from black and white lung cancer cases (Aim 2).
Second, we will test the effect of exposure to violence on an inflammatory response (hair cortisol) and lung
cancer screening outcomes by conducting a prospective survey and data collection with high-risk black men
(Aim 3). Finally, we will build a multilevel, context-specific lung cancer risk profiles (Aim 1) that take into
account not only individual behavioral risk (smoking), but neighborhood stress (exposure to violence),
physiological inflammatory responses (increased cortisol), and molecular changes (PRMT6 overexpression).
To develop such risk profiles, we utilize a composite population data approach to establish accurate counts of
all individuals within census tracts with sociodemographic, behavioral, and neighborhood risk profiles.
The strength of RECODE is its innovative approach to unveil a social epigenetic mechanism of lung cancer
disparity. RECODE has the potential to transform understanding multilevel risks of lung cancer and improve
the national lung cancer screening guidelines to reflect the social conditions of racial minority communities.

Public health relevance
PROJECT NARRATIVE This application proposes to 1) examine mechanisms of neighborhood social, economic, and environmental risks for lung cancer incidence and stage at diagnosis, 2) to identify the relationship between neighborhood risks and PRMT6-mediated epigenetic changes, and 3) to explore the relationship between neighborhood risk and hair cortisol levels among high-risk individuals. Although the link between neighborhood context and lung cancer outcomes has been documented, little is known about specific mechanisms through which neighborhood context affects biological and behavioral risks for lung cancer outcomes. This study examines neighborhood contextual factors that may contribute to understanding epigenetic changes and lung cancer risk.